Retinoid Signaling and Homeostasis in the Eye

SUMMARY
This proposal describes experiments to investigate the role played by STRA6 in modulating transcription of
genetic pathways in the RPE. Mutations in human STRA6 are associated with Matthew-Wood syndrome, whose
symptoms include microphthalmia-anophthalmia, as well as pulmonary hypoplasia. STRA6 is found on the
surface of many blood-tissue barrier epithelia, including the RPE. Though almost exclusively described as a
retinoid transporter, STRA6 also is a cytokine signaling receptor, whose function in this role has only been
studied in non-ocular tissues. This provokes exciting speculation into its role in the RPE of the eye: what
molecular signaling is controlled by STRA6 in the RPE? How do the genes whose expression is
modulated by STRA6 contribute to RPE function or survival? Which pathway(s) are important to maintain
the health of the RPE, which sustains the photoreceptors? We will use zebrafish as a cone-rich model
system to address these questions. Our proposed research has three Specific Aims: (1) to uncover molecular
signaling important for RPE function whose expression is modulated by STRA6, (2) to dissect the contributions
from individual signaling pathways to the RPE by making precise pathway-specific amino acid changes to
STRA6, and (3) to inactivate genes whose expression is altered by STRA6 inactivation to understand their
contribution to RPE function and survival. We have used CRISPR/Cas9 approaches to inactivate both STRA6
and its ligand RBP4 to profile their contribution to transcriptional modulation in the whole animal eye and in
isolated human RPE culture. Together, our results will shed light on the under-appreciated role of STRA6 in RPE
homeostasis and maintenance, while providing novel opportunities to develop treatment strategies to aid survival
of RPE cells to prevent or combat retinal disease. This proposal directly addresses emerging needs outlined in
“NEI Strategic Plan – Vision for the Future 2021-2025”. Specifically, we will i) address gaps in animal models,
such as a model with a high density of cone photoreceptors; ii) explore strategies to treat complex disease such
as modulating the expression of specific genes or gene editing; iii) examine the roles of redox biology and
mitochondrial function in ocular health; and iv) identify ocular disease genes to develop new strategies, models,
and tools for elucidating genetic and environmental interactions at the cellular and systems level, and thereby
accelerate mechanistic understanding and therapy development.

Public health relevance
NARRATIVE This project is of benefit to public health because, as visual disorders are on the rise, there is a greater need than ever to both understand the root causes of retinal degenerations, and to use this knowledge to develop preventive treatments and restorative therapeutics. We will use the cone-rich zebrafish animal system to dissect the role(s) played by STRA6 to modulate retinoid and JAK-STAT signaling in the RPE, examining the contribution of STRA6 to RPE cell survival and function. These studies will shed light on novel functions and mechanisms of STRA6, whose previous annotation has focused almost exclusively on its role as a retinoid transporter to maintain the visual cycle, and, in doing so, we will uncover new targets and routes of intervention to prevent loss of RPE cells, which underpin the health of the photoreceptors.